Dartmouth Cystic Fibrosis Training Program

In this application, we propose continued funding to the Dartmouth Cystic Fibrosis Training Program
(DCFTP). Continuing support is sought for a comprehensive, highly interactive, interdepartmental training
program with an emphasis on CF basic and translational science. The overall philosophy of the program
is to use a disease-centered approach to teach fundamental concepts of basic and translational
science in the context of a dynamic, multidisciplinary research and team-based mentoring
environment. In this submission, we propose to directly fund 4 Trainees annually. Our program has pooled
the talents of 22 dedicated Faculty Trainers from a wide range of departments—our current program
includes faculty in the departments of Biochemistry and Cell Biology, Chemistry, Molecular Systems
Biology, Medicine, Microbiology/ Immunology, Epidemiology, Pediatrics, and Engineering—to provide
instruction in CF-related research to PhD and MD/PhD students. The DCFTP will function in the context of a
Research Base already rich in basic, translational, and clinical CF-related studies. The CF research
program at Dartmouth has grown from three investigators and one NIH grant in 1997 to a community of
world-class scientists that currently secure $21.1M per year in direct costs of research funding ($0.96M per
investigator average). Dartmouth will also provide ~$39.6M in institutional support, including direct support
to DartCF, our training program and the affiliated graduate programs, over the next 5 years. Our Training
Faculty use approaches including the study of clinical cohorts, quantitative methods, and
laboratory-based and animal studies; thus, our trainees are exposed to a broad range of scientific
strategies to answer impactful scientific questions. The DCFTP participating Training Faculty, which
include PhD, MD, and MD/PhD researchers, work in a range of disciplines, with CF research as the central
focus; all Training Faculty conduct research, are well funded, and teach and mentor our Trainees. This
group of basic and physician-scientist researchers is actively engaged in CF-related research, with
expertise in cell biology, structural biology, microbiology, immunology, microbiome, genetics, bioinformatics,
statistics, and proteomics. A hallmark of our program is the close and consistent interaction of our Training
Faculty with our DCFTP Trainees via DCFTP-sponsored general and Trainee-specific activities, including
weekly research meetings, courses, journal clubs, and our annual retreat. Training-grant funds and DCFTP-
sponsored, Trainee-specific enhanced activities provide a unifying base that greatly facilitates the strikingly
interactive nature of this group (evidenced by 38 collaborative publications over the past ~5 years among
our 22 Training and 9 Affiliated Faculty) and of the collaborative grants held by these faculty.

Public health relevance
Project Narrative This training program provides research training and curricular-based training to a pool of talented, highly motivated students recruited into our Trainers’ laboratories, with training focused on cystic fibrosis (CF) to provide a disease-centric but widely applicable learning experience. Students are nurtured in a highly interactive environment; all trainees enroll in a core course, several courses in ethics, several advanced courses, and career development workshops pertinent to their area of research training. In addition to participating in weekly seminar series and journal clubs and presenting their work at joint lab meetings, retreats, an annual graduate program Research in Progress seminar, and annual Dartmouth CF Retreat open to all members of DartCF, Trainees supported by this T32 award are also provided with a series of additional enrichment activities, including attendance at the CF Clinical Conference, seminar speaker invitations, funds for travel to meetings and to attend off-site courses and career workshops, supplemental guidance with Individual Development Plans, the ability to present at the Dartmouth CF Retreat, and leadership and mentored teaching opportunities.